Exploring a new model to study developmental eye diseases

PROJECT SUMMARY
Defects in human eye development can result in a broad spectrum of ocular disorders, many of which lead to
partial or complete vision loss. The human eye is comprised of many specialized tissues derived from
different primordial cell lineages, and their formation is highly coordinated over time, making ocular
development a very complex process. Human ocular cell culture systems commonly used for disease
modeling fail to recapitulate earlier stages of this stepwise developmental process. Consequently, it remains a
challenge to efficiently test how patient variants impact developing structures within the eye, thus contributing
to the observed complex ocular phenotypes. To overcome this barrier, we aim to explore the recently
presented cell culture model where human iPSCs are induced to form multiple ocular cell types organized
within four identifiable, concentric zones - referred to as self-formed ectodermal autonomous multi-zone of
ocular cells (SEAMs). Uniquely, each zone is comprised of different cell types found within the eye, including
neuroretina, retinal pigmented epithelium, cornea and lens, and zone formation occurs progressively over
time, mimicking the timing and cell-cell coordination observed during human eye development. The primary
objective of this proposal is to delineate quantifiable morphological benchmarks and gene expression
signatures associated with SEAM generation under normal conditions and then test this model by introducing
disease-associated genetic variants in well-known ocular genes. Specifically, we aim: (1) To characterize
SEAM morphology, variability and gene/protein expression during their formation; (2) To explore the effects of
pathogenic human variants in key ocular genes on SEAM formation. In our approach we will measure
changes in size, shape, and other physical characteristics and appearance of SEAMs at four timepoints along
the differentiation process. Concurrent scRNA-seq analysis will define the identity of the cell types within the
multi-zones and determine their equivalence to developing human ocular tissues. These analyses will be
established first under normal conditions and then extended to assessing SEAMs derived from hiPSCs
carrying pathogenic variants in well-known ocular genes (PAX6 and FOXE3). Completion of these studies will
identify strengths and possible limitations of this innovative model system for studying human whole eye
development. Thus, this study will likely provide a platform for testing a wide range of genetic variants
identified in congenital ocular phenotypes including identification of the direct and secondary effects of those
variants on coordinated development of various ocular tissues.

Public health relevance
PROJECT NARRATIVE In this proposal, we aim to explore the recently presented cell culture model mimicking human whole eye development for its applicability in studies of a broad spectrum of ocular disorders, many of which lead to partial or complete vision loss. The development of this model is significant because it will provide a platform for testing a wide range of patient variants and assist in the identification of novel disease mechanisms and genetic diagnoses.